Emotion dysregulation across generations: Identifying early developmental and clinical indicators of risk

Project Summary/Abstract
Not applicable for this supplement proposal.

Public health relevance
Project Narrative Not applicable for this supplement proposal.